Animal Core

The Animal Core will provide essential services and facilities to the preclinical projects in a
standardized and efficient manner, utilizing shared facilities, equipment, and personnel in a
coordinated fashion. The services to be provided to each preclinical project are divided into
three specific aims. Dr. Christopher Peters will oversee the Animal Core and will meet with
monthly or as needed with Drs. Boada, Martin, Romero-Sandoval to assure that the Core
efficiently performs these three key functions. Dr. Peters will provide oversight for regulatory
affairs within the Program regarding animal use including approval and compliance with
protocols for the IACUC and Biohazard Safety Committee. Specific Aim 1 is to provide
standardized in vivo surgical and behavioral procedures in animals utilized by preclinical
projects. Both projects involving animals require animal procurement and identification, surgical
preparation and behavioral assessment of sensory and affective pain related outcomes. Specific
Aim 2 will provide standardized methods for collection of plasma and brain tissue and sample
preparation for determination of oxytocin levels as part of PK/PD studies. We will standardize
immunohistochemical approaches across preclinical projects for verification of viral mediated
protein expression in discrete populations of neurons in brain or spinal cord tissue. These
services include sacrifice and transcardial perfusion with paraformaldehyde, tissue harvest,
cryoprotection and cryosectioning, immunohistochemistry, and fluorescent microscopy including
data collection and analysis Specific Aim 3 will provide for generation of and maintenance of a
novel transgenic oxytocin-cre rat colony. Dr. Romero-Sandoval will assist with colony
management, breeding and genotyping to ensure sufficient animals are available in a timely
manner for preclinical studies in Project 2. These essential functions will standardize and
coordinate services and procedures throughout the Program and provide an efficient and
costeffective structure for collaboration.

Public health relevance
The Animal Core will provide essential services and facilities to the preclinical projects in a standardized and efficient manner, utilizing shared facilities, equipment, and personnel in a coordinated fashion. The services provided to each preclinical project include animal procurement, identification, transgenic colony management, surgical preparation and behavioral assessment. The Core will also standardize methods for collection of plasma and brain tissue for assessing oxytocin levels and for immunohistochemical verification of efficient viral vector transduction and ablation.